Notch signaling in diabetic wounds

PROJECT SUMMARY/ABSTRACT
Non-healing wounds in patients with Type 2 Diabetes (T2D) are a major cause of increasing morbidity and
mortality. Failure of wound healing in T2D patients represents the most common cause of amputation in the US
with a 5-year mortality rate of nearly 50%. Thus, a critical need exists for understanding the wound healing
defects in T2D in order to develop targeted therapies. We have utilized both genetic (db/db) and dietary (diet-
induced obese) murine models of T2D as well as human wound tissue and blood samples collected from T2D
patients to explore mechanisms of impaired wound healing. Our published and preliminary data demonstrate that
interactions between wound macrophages (Mφs), and CD4+T cells, via Notch signaling, dictate CD4+T cell
activation to ultimately regulate inflammation and healing in wounds. We and others have identified that a wound
CD4+Treg cell phenotype is critical for normal tissue repair, while a TH17 phenotype promotes excess
inflammation and impairs healing. Our preliminary data identify TLR4 signaling in wound Mφs upregulates the
Notch ligand, DLL4, which then interacts with the Notch 1 and 2 receptors on CD4+T cells to promote TH17 as
opposed to Treg differentiation. These interactions drive excess inflammation and pathologic healing in diabetes.
Additionally, the DLL4-Notch pathway may be further upregulated in diabetic wounds via epigenetic mechanisms
involving MLL1, a histone methyltransferase. MLL1 directly upregulates DLL4 in Mφs and can indirectly increase
DLL4 via TLR4 signaling in Mφs. In addition, MLL1 can directly increase Notch 1 and 2 receptor expression in
CD4+T cells, making them more receptive to Notch activation and promoting a prolonged TH17 response. These
changes then dictate the pathologic TH17 phenotype in diabetic wounds. These results have led to our
hypothesis that DLL4-mediated Notch receptor signaling in diabetic wounds polarizes CD4+T cells in the wound
towards TH17 and promotes chronic inflammation and non-healing. Further, increased downstream IL17A
signaling increases epidermal and dermal cell mediated inflammation in diabetic tissue. Our data suggest that
wound Mφ/CD4+T cell wound phenotypes may be restored via Mφ-targeted treatment (delivered locally to the
wound via engineered nanoparticles) with MLL1 inhibitor(s) or local treatment with anti-DLL4 antibodies. To test
our hypotheses, we will pursue the following aims: Aim 1: To examine the direct (MLL1) and indirect
(TLR4/MyD88) regulation of DLL4 in wound macrophages during normal and diabetic conditions. Aim 2:
To identify the role of Notch receptor activation on Treg/TH17 differentiation during normal and diabetic
wound repair. Aim 3: To compare local and Mφ-targeted therapies to reduce Notch signaling, limit TH17
differentiation, improve healing and identify the cellular targets for IL17A signaling in wounds.

Public health relevance
PROJECT NARRATIVE Impaired immune cell response leading to chronic inflammation is a major cause of non-healing diabetic wounds. We have identified that increased Notch signaling in diabetic wounds polarizes CD4+T cells in the wound towards an inflammatory TH17 phenotype. This proposal will seek to understand the mechanisms responsible for the altered Notch signaling and will test new cell-targeted nanotherapies to restore immune cell homeostasis and healing in wounds.